Comparative Medicine and Pathology Training

Project Summary/Abstract
The Comparative Medicine and Pathology training program was initiated in the fall of 2003 and provides state-
of-the-art research training to veterinarians. Five years of continuing support are requested in the present
application, including support for six trainees in each year of the program. It is anticipated that the majority of
these individuals will have completed a residency in medicine, surgery, or pathology prior to entering the
training program. Selection criteria will include: 1) strong interest in research and a desire for a career in
academic veterinary medicine; 2) academic credentials and performance during clinical training/residency; and
3) desirable personal characteristics, including integrity, perseverance, and oral and written communications
skills. The training program is located in the College of Veterinary Medicine at the University of Minnesota and
is directed by Drs. Cathy Carlson, David Brown, and Molly McCue. Thirty-three faculty mentors, all members of
the Comparative and Molecular Biosciences (CMB) and/or Veterinary Medicine (Vet Med) graduate programs,
will participate in the training program. These individuals represent a diverse group of disciplines, including
pharmacology, cell biology, infectious disease, neurobiology, physiology, genetics, molecular biology, and
orthopedics. Trainees without a PhD degree will pursue a PhD in the CMB or Vet Med graduate program, well-
organized, multidisciplinary graduate programs created to focus graduate education efforts by faculty
interested in comparative biomedical sciences and the molecular mechanisms responsible for human and
animal health and disease. The goals of our programs are to provide students with the broad-based
knowledge, quality communication skills, and advanced research training essential for a career as independent
investigators.

Public health relevance
Project Narrative This program is highly relevant to public health, as it addresses the ongoing serious shortage of veterinarians with the research expertise necessary to pursue a career as independent investigators in biomedical research. These individuals are critical to the effective translation of biomedical research discoveries made in animal models to new methods of diagnosis and treatment of disease in humans.